Reagents for Immunologic Analysis of Under-represented Mammalian Models

Integral Molecular proposes to generate a large panel of pan-reactive monoclonal antibodies (mAbs) against immune cell markers to be used in studies of immune function and responses in nine underrepresented mammalian models. Since certain mammalian models display many features of human immunity but are similarly underutilized due to lack of immunologic reagents, development of cross-reacting antibodies to study immune responses in several animal species will impact the understanding of several human diseases.